Stanford Molecular Imaging Scholars (SMIS)

PROJECT SUMMARY/ABSTRACT The Stanford Molecular Imaging Scholars (SMIS) program is an integrated, three-year cross-disciplinary postdoctoral training program at Stanford University that brings together 33 faculty mentors from 14 departments in the Schools of Medicine, Engineering, and Humanities and Sciences. Molecular imaging, the non-invasive monitoring of specific molecular and biochemical processes in living organisms, continues to expand its applications in the detection and management of cancer. We propose to train, on average, 8 postdoctoral trainees per year (comprising 1st, 2nd, and 3rd year fellows). SMIS faculty mentors provide a diverse training environment spanning biology, physics, mathematics, biocomputation/biomedical informatics, engineering, chemistry, biochemistry, cancer biology, immunology, and medical sciences. The centerpiece of the SMIS program is the opportunity for trainees (PhD or MD with an emphasis on PhD) to conduct innovative molecular imaging research that is co-mentored by faculty in complementary disciplines. SMIS trainees also engage in specialized coursework, seminars, national conferences, clinical rounds, including ethics training and the responsible conduct of research. The three-year program culminates with the preparation and review of a mock NIH grant proposal, in support of trainee transition to an independent career in cancer molecular imaging. During the first two award cycles 28 trainees have entered the SMIS program; 6 are currently enrolled and 22 have completed the program as of this writing. Those who have moved on are either in faculty positions, other academic positions, or working in biotechnology. Demand for the SMIS training is high; we now receive, on average, more than 20 applications per year from qualified candidates seeking placement in our program, which can accommodate only 2-4 new trainees per year. For the upcoming cycle, we propose an enriched SMIS program that achieves the following: expansion of our Program Area in Chemistry of Molecular Probes; strategic selection of additional faculty mentors; improvement in all other training and career development components; expansion of leadership for our mock grant proposal activity and our clinical exposure component; and recruitment and retention of underrepresented minority candidates. The goal of the SMIS program is to continue to provide talented young investigators with the scientific and professional education/career development opportunities to become leaders in the field of molecular imaging of cancer.

Public health relevance
RELEVANCE TO PUBLIC HEALTH The Stanford Molecular Imaging Scholars (SMIS) program is an integrated, cross-disciplinary postdoctoral training program that prepares young investigators for research careers in the field of molecular imaging of cancer. Molecular imaging is a science that allows visualization of specific molecular and biochemical processes in intact living organisms, and provides powerful tools for the study of disease. SMIS trainees develop innovative molecular imaging approaches for the diagnosis and management of cancer, including the development of novel probes, guiding the selection and/or discovery of novel treatments, and evaluation of therapy response.